Visual Function Core

During past year, NEI visual function core (VFC) continues to provide service and support to the NEI and NIH scientific community and to extramural researchers on non-invasive methods to evaluate visual function in various animal models. Both virtual and in-person supports are adopted by the core to provide service to vision research environment. VFC coordinated with researchers and NEI Veterinary Research and Resources section (VRRS) to monitor cleaning and disinfection procedures after each use of core instruments.

While electrophysiological recordings and eye imaging constituted most of the core service, behavior tests to determine opto-motor responses were also used by our researchers. NEI-VFC has helped users in design ERG recording and OCT imaging protocols specific for each research projects. In addition, VFC also assisted researchers in data analysis. VFC further enhanced AI-based OCT image segmentation tool to analyze OCT images captured from mouse eye. Main accomplishments of the core for past year include:

1) Performed maintenance of all core equipment to ensure their optimal performance.

2) Coordinated with VRRS for periodic inspection and examination of the facility and instrument to ensure complete disinfection.

3) In collaboration with OISO/BioTeam, a virtual computer was constructed for analyzing data acquired with VFC instruments.

4) Provided training and supervision to researchers on using core equipment.

5) Provided training to scientific personnel on data analysis software. Use virtual communication to enhance user experience.

6) Providing consultations on using non-invasive methods to evaluate visual function to extramural research groups.

VFC provided training and help to users on analysis methods of electrophysiological, eye imaging, and behavior data, and on tools of generating final reports. Core also provided directions and instructions on installation of software needed for electrophysiological recording, behavior testing, and eye image data analysis.

In addition, core provided consultations and advises on various research projects. During the past year, core provided service and training to 36 scientists in 15 research groups (PIs). NEI-VFC also provided consultations to several extramural research groups.